Proteomics Core

OK-INBRE Proteomics Core - Summary
The goal of the OK-INBRE Proteomics Core is to provide researchers in Oklahoma and in all
IDeA-eligible states access to state-of-the-art instrumentation and expertise for advanced mass
spectrometry (MS). The core is equipped with the instrumentation and expertise required to
make discovery proteomics and targeted quantitative proteomics experiments available to
researchers in Oklahoma. The discovery proteomics experiments (Specific Aim 1) will use data-
dependent analyses to acquire high resolution survey scans to determine peptide mass with
high accuracy and collision induced dissociation (CID) spectra to determine the amino acid
sequence. Database searches then identify the proteins and find posttranslational
modifications. The targeted quantitative proteomics experiments (Specific Aim 2) will use
selected reaction monitoring (SRM) and parallel reaction monitoring (PRM) to selectively detect
and quantify proteins based on peptides formed by trypsin digestion. To ensure statewide
awareness of the core's capabilities and access to these methods (Specific Aim 3), the OK-
INBRE Proteomics Core laboratory will, i) continue to offer educational workshops and develop
on-line materials to describe our methods and educate potential users and ii) provide vouchers
to defray costs associated with pilot projects to enhance utilization of the OK-INBRE Proteomics
Core. Finally, the OK-INBRE Proteomics Core will continue to function as the Targeted
Quantitative Proteomics component of the IDeA National Resource for Proteomics that provides
access to advanced proteomics methods and education for Core Directors, trainees, and
researchers from all IDeA-eligible states.